Engineering bZIP family transcription factors for therapeutic T-cell persistence and effector function

PROJECT SUMMARY
Cancer immunotherapy using T cells engineered with a chimeric antigen receptor or T-cell receptor directed
against cancer antigens is a promising new therapeutic modality for treating many types of cancer. However,
lack of efficacy due to T-cell dysfunction, particularly in the solid tumor setting, has stymied progress. Multiple
stressors exist within tumors that drive T cells to a dysfunctional state, reducing their ability to clear tumors.
Genes have been identified that improve T-cell resilience to different tumor stressors. However, these genetic
modifications that improve T-cell exhaustion resistance often act via different mechanisms, creating uncertainty
regarding the relative benefit of different approaches or how to combine them for maximum efficacy.
Altering transcription factor activity is a particularly robust way to favor a functional therapeutic cell state. The
field has identified transcription factors that can be overexpressed to promote retention of T-cell effector activity
or a more persistent, stem-like state. Additional transcription factors have been identified that promote
dysfunction downstream of chronic antigen signaling or in response to metabolic conditions in the tumor
microenvironment and can be knocked out to favor retention of T-cell activity. Both approaches have yielded
improvements in tumor control in preclinical models, but the use of different models and conflicting results leaves
uncertainty about which modifications are most beneficial and their mechanism. We intend to use protein
engineering to create protein-based inhibitors that bind and prevent the function of transcription factors when
overexpressed in T cells. This will allow the creation of overexpression libraries with members that can both
decrease and increase transcription factor activity to facilitate the comparison of genetic modifications in T cells.
The goals of this Steven I. Katz proposal are to: 1) Understand the molecular mechanism of the transcription
factors complexes regulating T-cell exhaustion, 2) Increase resistance to T-cell dysfunction through systematic
multiplexing of transcription factor perturbations, and 3) Determine the relative benefit of transcription factor
perturbations that counter different sources of T-cell dysfunction in the in vivo tumor microenvironment. As
specified by the funding mechanism, this proposal sets forth an important new research direction for our lab in
the areas of T-cell dysfunction and engineering of endogenous transcription factors and is well-based in
published literature and supported by subject matter experts and collaboration. Through screening of pooled
libraries and parallel characterization of a matrix of multiplexed engineered transcription factors using in vitro
and in vivo models of tumor-induced T-cell dysfunction, this proposal will address the important question of which
transcription factor perturbations are most effective in promoting resistance to T-cell dysfunction. Using cutting-
edge single-cell RNA-seq mapped to transcription factor perturbations, we will determine the effect of these
modifications on T cells in murine tumors. This grant will yield new transcription factor engineering solutions to
improve therapeutic cells, generating biological insight and new research paths in cell therapy engineering.

Public health relevance
PROJECT NARRATIVE Using immune cells to target and kill tumor cells is a promising therapeutic approach but currently lacks efficacy for many cancers due to the dysfunction of the immune cells in the tumor. This proposal seeks to identify the optimal modifications to genetically engineer into immune cells to help them resist dysfunction. By engineering new ways to control the transcriptional state of the immune cell, our approaches will improve the anti-tumor efficacy of T cells for multiple cancer types.